Administrative Core

PROJECT SUMMARY
The Northwestern HeartShare Data Translation Center (DTC), leverages processes, personnel, and
infrastructure from the Northwestern University (NU) Data Analysis and Coordinating Center (NUDACC), to have
the staffing, equipment, and other resources available to ensure that the Administrative and Outreach Core
meets its goals of (1) designing, implementing, and integrating the HeartShare program components; (2)
coordinating and optimizing the data ascertainment from the electronic health records (EHRs) at the HeartShare
Clinical Centers (CCs); (3) ensuring successful enrollment and retention of heart failure (HF) patients and
controls for the prospective component of HeartShare; (4) supporting a call center and integrating with the Eureka
platform, which will facilitate acquisition of mobile health data and contact with patients; (5) providing consistency
and standardization of data acquisition across the CCs and establishing core laboratories; and (6) developing a
Research Skills Program, which will be modeled after Northwestern’s innovative Computer Science-X (CS-X)
Program, which has successfully bridged the divide between cardiology fellows and post-doctoral data scientists
via integration with Northwestern Bluhm Cardiovascular Institute’s Center for Artificial Intelligence in
Cardiovascular Medicine Fellowship Program. The HeartShare DTC Administrative and Outreach Core also
leverages the resources of the Institute for Augmented Intelligence in Medicine (I.AIM) at Northwestern. The
HeartShare Administrative/Outreach Core is designed to complete the following specific aims. (1) To design,
implement, and coordinate the HeartShare program components to ensure the successful completion of the
retrospective and prospective aspects of the program. We aim to provide guidance to sites and monitor metrics
for HFpEF patient enrollment, engagement, and retention; ensure data consistency and standardization across
sites; and provide administrative, financial, and scientific leadership of HeartShare. (2) To create a state-of-the-
art HeartShare Call Center integrated with the Eureka platform that will facilitate acquisition of mobile health
data, outside records, and longitudinal contact with patients, which will be essential for developing a
comprehensive HeartShare data repository and will facilitate longitudinal follow-up. (3) To create an innovative
Research Skills Program that will provide high-quality mentoring and synergy for early-stage clinical investigators
and data scientists using the successful Northwestern CS-X program as a blueprint.